Norepinephrine tunes prefrontal-thalamic circuitry to modulate avoidance behavior

Norepinephrine tunes prefrontal-thalamic circuitry to modulate avoidance behavior
Abstract
Anxiety disorders are the most common mental illness in the U.S., affecting ~18% of the population. However,
the underlying mechanisms associated with anxiety remain elusive. Recent evidence has identified the medial
prefrontal cortex (mPFC) as a crucial regulator of anxiety and disruption of mPFC-mediated executive functions
in anxiety disorders. On the other hand, norepinephrine (NE) has long been associated with stress and anxiety.
A morphological study showed a higher density of dopamine beta-hydroxylase (DBH) varicosities in the PFC
than in other cortices. However, how the mPFC executes top-down control over other brain regions to regulate
anxiety-related approach-avoidance behavior and whether and how this is modulated by norepinephrine (NE)
remain unclear. This project will test the innovative concept that mPFC – paraventricular thalamus (mPFC-PVT)
circuit is an important previously overlooked target for anxiety and decision-making. Our pilot study suggests
that chemogenetically inhibiting mPFC-PVT pathway with DREADD viral victor significantly increased the time
spent in the open arm of the elevated plus-maze, indicating a reduction in anxiety-related avoidance behavior.
We thus hypothesize that mPFC-pPVT neurons are active during the exploration of aversive environments,
which drives avoidance behavior and elicits anxiety-dependent behaviors. We will explore the extent that
prefrontal NE signaling modulates this effect. We will investigate the communication between these two regions
by using calcium imaging, a detailed DeepLabCut analysis of animal’s behavior (Aim 1) combined with a G-
protein-coupled receptor (GPCR) Activation-Based Norepinephrine (GRAB-NE) sensor (Aim 2) for anxiety-like
behavior. The GRAB-NE will allow us to monitor prefrontal NE dynamics in real-time in free-behaving animals.
The DeepLabCut™ will provide a detailed analysis of an animal’s posture with a sub-millisecond temporal
resolution that could be used to determine an animal’s emotional state change. In summary, we address these
conceptually innovative questions using state-of-the-art methods, which allow for precise, causal interrogation
into the role of this circuit both in vivo and ex vivo in a projection-specific manner.

Public health relevance
Narrative Avoidance behaviors are key features of anxiety, but the neural circuitry mediating these behaviors remains unclear. This project aims to elucidate how neural activity in prefrontal neurons projecting to the posterior paraventricular thalamus regulates avoidance behaviors and decision making and reveal for the first time the underlying neural modulatory mechanisms associated with norepinephrine in these two important brain regions.